Small Molecule KLF15 Agonists for Kidney Disease

The Centers for Disease Control and Prevention estimates more than 15% of adults in the United
States, over 30 million Americans have chronic kidney disease (CKD). Podocytes are epithelial cells in the
glomerulus whose major function is the maintenance of the kidney filtration barrier to prevent CKD.
Furthermore, the prevalence of CKD in the Veteran population is a third higher than in the general population.
Podocyte injury is implicated in diseases such as Focal Segmental Glomerular Sclerosis (FSGS). In these
diseases, the podocyte loses characteristic morphologic features and the functional capacity to maintain the
glomerular filtration barrier. In several recent studies, we reported the essential role of Krüppel-Like Factor 15
(KLF15), a kidney-enriched transcription factor, in maintaining podocyte actin cytoskeleton under cell stress.
For instance, loss of function studies in preclinical proteinuric murine models demonstrated that KLF15 is
required to prevent podocyte injury and the salutary benefits of glucocorticoids (GCs), the most common
treatment for primary glomerulopathies, are mediated by KLF15. As well, the responsiveness to GCs in human
primary glomerulopathies is associated with podocyte-specific expression of KLF15. Furthermore, induction of
human KLF15 in podocytes attenuated kidney injury in proteinuric murine models, without the adverse
sequelae of GCs. Collectively, these preclinical and clinical studies on the renoprotective effects of KLF15
induction motivated us to identify novel small molecule KLF15 agonists for kidney disease.
We initially generated and conducted a cell-based high-throughput screening (HTS) to screen small
molecules that induce KLF15 activity. Subsequent dose-escalating studies identified novel lead compounds
with a half maximal effective concentration (EC50), in the optimal therapeutic window, required to induce KLF15
activity. Based on EC50 and druggability, we conducted Structure-Activity Relationship (SAR) on the lead
compound K-7 and generated 16 lead analogues, of which BT501, BT502, BT503, BT514, and BT412 induced
KLF15 promoter activity with or without cell stress. We also performed intial pharmacokinetic studies for K-7 in
mice and also showed that human podocytes treated with K-7 and lead analogues attenuated podocyte injury
in the setting of cell stress. Furthemore, RNA-seq of K-7 treated human podocytes shows inhibition of pathway
IL-17RA-mediated actin cytoskeleton destabilization, thereby providing the rationale to utilize a mechanistic
approach to optimize selectivity of KLF15 agonists. Finally, we observed that K-7 attenuated albuminuria and
restored podocyte markers in a preclinical proteinuric murine model. Based on these compelling preliminary
data and strong scientific rigor of prior research, we hypothesize that optimization of lead KLF15 agonists in
preclinical studies will serve as a key therapeutic in proteinuric kidney diseases. We propose to test our
hypothesis by (1) improving the pharmacodynamic and pharmacokinetic properties of lead KLF15 agonists, (2)
utilizing a mechanistic approach to optimize selectivity of KLF15 agonists, and (3) testing the therapeutic role
of lead KLF15 agonists in mitigating and/or reversing kidney injury in preclinical proteinuric models.
This proposal will address a current gap in the field by developing an integrated framework to optimize
lead novel KLF15 agonists and test their therapeutic role in preclinical proteinuric models. The long-term goal
of our project is to identify the optimal KLF15 agonist that can be advanced for IND studies for the treatment of
primary glomerulopathies. Identification of novel targets for the treatment of proteinuric diseases is of major
interest to the VA, given the high burden of CKD among U.S. Veterans. Furthermore, therapeutic strategies
that mitigate the long-term use of GCs will have a tremendous impact on the complications associated with
GCs in U.S. Veterans. Finally, the therapeutic role of KLF15 induction might extend beyond kidney disease, as
other laboratories have demonstrated the beneficial effects of KLF15 in cardiac hypertrophy,
neurodegenerative disease, and adipogenesis.

Public health relevance
The CDC estimates more than 30 million Americans have chronic kidney disease (CKD), with a disproportionate burden on U.S. Veterans (prevalence a third higher than the general population), and we have no sustainable therapeutic strategies to prevent or reverse CKD. As such, the Department of Veterans Affairs and the current White House administration underscored the importance of new therapeutics. Podocytes are epithelial cells in the kidney whose major function is the maintenance of the kidney filtration barrier to prevent CKD. Injury to podocytes has been implicated in many glomerular diseases, but therapies targeting podocyte dysfunction are limited. Our proposal will address this current gap in the field by developing an integrated framework to optimize lead novel small molecule agonists to a critical regulator of gene expression (Krüppel- Like Factor 15) and test their therapeutic role in preclinical proteinuric models. Therefore, the studies we propose are highly significant and clinically relevant to the Department of Veterans Affairs.